A novel producer cell line for more efficient manufacturing of viral vector systems

ABSTRACT
Significant advances in the specific targeting of delivery vectors and the increased therapeutic efficacy of such
vectors for gene delivery have been made, stimulating major interest in the development and
commercialization of therapeutic products focused on gene therapy indications. CLAIRIgene LLC focused on
the development and optimization of various viral gene-to-cell transfer delivery platforms targeted a broad
range of applications, including CRISPR/Cas9 systems. Of the gene therapy products in development, we
focused on recombinant Adeno-Associated Virus (AAV)-based vectors and Integrase-Deficient Lentiviral
Vectors (IDLVs), as they show the greatest potential for delivery in gene therapy indications. Both systems
operate at transient “hit-and-run” mode, associated with minimal integration levels, which substantially reduces
the risk of insertional mutagenesis, oncogenesis and other associated toxicities, therefore is highly
advantageous for gene therapy applications. Furthermore, we recently evolved these non-integrating vectors
onto efficient and safe delivery vehicles for gene-to-cell transfer of CRISPR/Cas9 components into various
primary cells and tissues, including post-mitotic neurons in vitro and in vivo. Notwithstanding these
advantages, episomal vectors, including IDLV and AAV expressed at relatively low levels, as their genomes
are packaged into heterochromatin structures, largely inaccessible by transcription machinery. Consistently,
we previously demonstrated that histone deacetylase inhibitors (HDACsi) added during vector production step
can dramatically increase its titer and transduction efficiency. Nevertheless, most small-molecule-based HDAC
inhibitors are non-selective, and evidently demonstrate high-level of undesirable off-target activities, including
cell cycle arrest, changes in cellular differentiation and apoptotic signaling. Therefore, more selective and
targeted strategies aimed to downregulate expression of HDAC-of-interest are needed. The current proposal is
based on our preliminary data demonstrated that class I of the HDAC family HDAC8 could play an important
role in the regulation of life cycle of episomal vectors, including AAV and IDLV. We have shown that vector-
producer cells, human embryonic kidney HEK293T knockouted for HDAC8 support the improved packaging
and titer of the vectors.
In the current proposal, we aim to create (i) a stable, monoclonal producer HDAC8-/- HEK293 cell line for more
efficient production of AAV and IDLV vectors. Following characterization and optimization, we aim to certify
the product for a range of gene therapy applications using viral vectors as delivery systems. To evaluate
whether the developed cells could be used universally for production of other non-integrating systems, we will
aim in the future testing them for manufacturing adenovirus (Ad), herpes simplex virus type I (HSV-1), and non-
human lentiviral vectors. The growing pipeline of cell and gene therapies has led to a substantial increase in
demand to high quality gene delivery vehicles; here, we believe that the improved producer cells will create a
significant business opportunity for us to support this demand.

Public health relevance
PROJECT NARRATIVE CLAIRIgene LLC is an early-stage start-up biotech company focused on the development and optimization of lentiviral vector (LV) and adeno-associated vector (AAV) systems, primarily for gene-editing applications using CRISPR/Cas9 technology. We use a rational design strategy for engineering novel and optimized vector- expressing cassettes aimed for the efficient and safe packaging of the vectors. In this proposal, we aim to develop novel vector-producer cell line- and expression characterized by improved packaging efficiency. The cell line will be used to enhance manufacturing protocols of production for a broad range of gene therapy products, especially those based on difficult-to-package CRISPR/Cas vectors carrying oversized and multi- modular components. This work is based on our recent data shown that the improvement in viral packaging efficiency and overall production of the viral vectors could be achieved via targeted depletion of HDAC8 enzyme from HEK293T producer cell line, which broadly used for the manufacturing of various viral delivery platforms, including IDLV and AAV. In this proposal, we aim to establish a stable and monoclonal HDAC8-/- HEK293 cell line; comprehensively access its efficiency and safety, and certify and commercialize the product for the broad range of gene therapy applications.